Panretinal Circular Ranging OCT for Retinoblastoma

PROJECT SUMMARY
Retinoblastoma (RB) is the most common primary intraocular malignancy of childhood. Although retinoblastoma
is an aggressive cancer, early diagnosis and treatment may prevent visual impairment, and even improve
mortality rates. This is particularly relevant for children at risk for retinoblastoma due to family history of the
disease, which can be inherited in an autosomal dominant fashion. These children benefit fromea rly and frequent
screening evaluations. Currently, RB diagnosis and management remains largely dependent upon
ophthalmoscopic evaluation by expert clinicians. Ophthalmoscopy offers panretinal imaging, but suffers from a
poor sensitivity to sub-millimeter (subclinical) tumors and a limited ability to monitor treatment response.
Handheld optical coherence tomography (HH-OCT) offers the promise to address both of these needs, but
technical deficiencies in imaging speed and axial range severely limit is clinica l utility. Recent innovations in
circular-ranging methods, stretched-pulse mode-locked frequency comb lasers, and ultrawide handheld
microscopes open new avenues for clinically meaningful deployments of HH-OCT in the management of Rb. In
Aim 1, we will integrate these innovative technologies into a prototype instrument providing panretinal high-
resolution three-dimensional imaging. In Aim 2, we will perform pilot imaging studies in sedated children
undergoing RB screening. Study data will be used to assess the feasibility of panretinal imaging by HH-OCT in
sedated children, to quantify RPE and ILM visibility as an image quality metric predictive of the instrument’s
ability to detect subclinical tumors, and to confirm that the volume of all imaged tumors, regardless of size, can
be calculated.

Public health relevance
PROJECT NARRATIVE Optical coherence tomography (OCT) is a widely used ophthalmic imaging technology uniquely able to image the eye with micron resolution over a large 3-dimensional volume. The proposed research will push its performance on the cutting edge of resolution, speed, range, and field of view, and investigate applications in retinoblastoma, the most common primary intraocular malignancy of childhood.